Mitigator Efficacies after Realistic Improvised Nuclear Device (IND) Exposure: MERIE

The need for improved radiation effect mitigators stems from the significant probability of the detonation of an
Improvised Nuclear Device (IND). Typically pharmaceutical radiation countermeasures have been tested
against x rays delivered over a few minutes. In practice, however, 1) the majority of the IND-related radiation
dose will be delivered by “direct” radiation from the IND, over a time period of less than a microsecond, and 2)
A significant component (10 - 50%) of the biological effect from a ground-burst IND will be from fission neutrons.
The biological effects and associated mechanisms from these IND-specific radiations are typically quite
different as compared with the corresponding effects and mechanisms associated with conventional x rays
delivered over a few minutes. In addition there is evidence that mitigator performance is different for these IND-
specific radiation types. It is therefore important to understand whether radiation countermeasures that have
been developed and tested against x rays delivered over time periods of a few minutes will also be effective in
these more realistic IND exposure scenarios. At Columbia University unique radiation sources are available to
simulate each of these IND-specific exposures. These tools will allow each of the Research Projects to
address the same common research themes:
1. Are radiation mitigators that were developed and tested with x rays irradiated over a few minutes, also
effective against a) very short, very high dose rate radiation exposures, b) IND-specific neutrons?
2. Using these realistic IND exposures, can mitigators developed for specific endpoints have utility for other
key radiobiological endpoints?
3. Using these realistic IND exposures, can combining multiple mitigators that were each designed for specific
endpoints, have increased overall utility if given in combination (“polypharmacy”)?
In this highly synergistic proposal, the Projects and Cores are tightly linked by common research themes
and hypotheses, by a shared animal model, and by shared samples and data. The WAG/RijCmcr rats that will
be used sequentially manifest our radiation endpoints of interest, allowing the sequential study in the same
irradiated animals of GI-ARS (Project 1), lung and kidney damage (Project 2) and cardiovascular damage
(Project 3). Each Project also features state-of-the-art pharmaceutical mitigators that have already been
designed and tested by the relevant project team, using conventional x rays for their respective endpoint. The
Proposal also features three strong central Research Cores (Radiation, Biomarker and Statistics), unifying the
Research Program. The 7 Project and Core Teams already have a strong track record of working together, with
>260 Team-Team interactions in publications, and >50 Team-Team interactions in grants - largely from NIAID
RNCP grants. Finally a highly experienced Administrative Core will provide fiscal management support and will
organize an annual 1.5-day retreat, coupled with a full-day training session targeting junior radiation scientists.

Public health relevance
Pharmaceutical radiation countermeasures for an Improvised Nuclear Device (IND) have typically been tested against x rays delivered over a few minutes, but in practice 1) the majority of the IND-related high radiation doses will be delivered by direct radiation over a time period of very much less than a second, and 2) a significant component of the biological effect will be from IND fission neutrons. For a sequential series of relevant endpoints, the Research Projects, supported by the Research Cores, address three common key themes: the effectiveness of radiation mitigators that were developed and tested with x rays given over a few minutes, against IND-specific radiations; the effectiveness of mitigators developed for specific endpoints, for other key radiobiological endpoints; the combination of multiple mitigators that were each designed for specific endpoints, if given in combination (“polypharmacy”).